The Roles of Social Reward Responsiveness and Interpersonal Stress in Mental Health Disparities in High-Risk Youth

Modified Project Summary/Abstract Section

Suicidal ideation (SI) is a strong predictor of suicide–the second leading cause of death for adolescents and a national public health priority–and occurs in a significant proportion of adolescents. Adolescents who are at an elevated risk for mental health disparities, such as sexual minority (SM) youth, show even greater prevalence of SI. Considering these high rates of SI in SM youth, it is critical to identify intervention targets as a first step in designing efficacious treatments to prevent death by suicide. One such intervention target may be low reward responsiveness, which is associated with SI above and beyond the influence of depression or anhedonia and tends to be blunted in SM youth, particularly within social contexts. Despite this association, no research has evaluated low social reward responsiveness as a mechanism of SI in SM youth. Further, no research has evaluated potential moderators, such as interpersonal stress, on the association among low social reward responsiveness and SI in SM youth. This is critical, as SM youth are at an increased risk of experiencing interpersonal stress and mental health disparities due in part to experiences of stigma, prejudice, and discrimination. The proposed project will address these gaps by testing a novel mechanism linking SM identity to increased SI risk and examining the moderating role of interpersonal stress, leveraging an innovative approach with a large high-risk sample of adolescents. The proposed study will test these pathways in a sample of 210 adolescents (aged 13-17) following discharge from acute psychiatric treatment for self-injurious thoughts and behaviors (SITBs). Based on prior research and our own work with adolescents in partial and inpatient treatment, we expect that ~50% of participants will hold an SM identity. Participants will undergo an electroencephalogram (EEG), answer self-report measures, and complete semi-structured interviews to characterize SITB history. Acute interpersonal stressors, social support, and suicidal behavior will be assessed using a brief daily survey for 90 days following discharge, with self-report and interview measures obtained at 3-month follow-up. Through the longitudinal collection of these data, the present study aims to (1) Examine patterns of social reward responsiveness at the neural level in SM youth compared to heterosexual youth in acute psychiatric treatment for SITBs; (2) Evaluate low social reward responsiveness as a mechanism underlying increased SI severity in SM youth after hospital discharge; and (3) Test interpersonal stress as a moderator in the relation between SM status, low social reward responsiveness, and SI. Through support granted by this fellowship, the applicant will have the opportunity to develop advanced EEG skills, gain a deeper understanding of risk for psychopathology and SITBs in SM youth, acquire proficiency in longitudinal data analysis, and receive individualized mentorship in grant writing and enhancement of professional skills. Funding from this fellowship will provide the applicant with the necessary skills for a successful career as a clinical scientist.

Public health relevance
Modified Public Health Relevance Section Adolescent suicide is a public health issue of critical priority, with rates rapidly increasing, and suicidal ideation (SI) is one of the most robust predictors of death by suicide. Adolescents who are at an elevated risk for experiencing mental health disparities, such as sexual minority (SM) youth, are also significantly more likely to experience SI; thus, identifying underlying processes that contribute to the development of SI in SM youth are crucial in order to pinpoint intervention targets to aid in preventing death by suicide. As part of a larger longitudinal study, the current proposal will evaluate a potential mechanism linking SM identity to increased SI risk via interactions with low social reward responsiveness and interpersonal stress – the proposed project will be the first to test this pathway by leveraging an innovative approach with a large high-risk sample of adolescents and will identify novel targets for intervention.